Research Project Core

SUMMARY – RESEARCH PROJECT
This project will characterize intra-urban inequities in the effects of extreme heat on mortality and examine
individual-level and neighborhood factors associated with these inequities in five cities of the Americas, one of
the most urbanized and unequal regions of the world. Understanding these inequities is critical for the
development of urban policies and practices aimed at reducing the inequitable impacts of climate change in
diverse urban populations. The combination of high levels of urbanization and associated heat island effect, an
aging population, and extreme levels of inequality and economic and racial residential segregation makes
urban populations in the region particularly susceptible to the effects of climate change. However intra-urban
inequities associated with neighborhood and individual-level characteristics have not been systematically
examined across multiple settings. A better understanding of how inequities in the impacts of heat on health
vary across cities and countries is critical to adaptation policies and strategies and for targeting of resources.
The overall goal of this project is to conduct policy-relevant climate change and health research across multiple
countries in the Americas by studying inequities in the impact of extreme heat in five cities in four
countries: Philadelphia (USA), São Paulo and Rio de Janeiro (Brazil), Guatemala City (Guatemala), and
Panama City (Panama). We will investigate both neighborhood and individual-level factors and disentangle
equity impacts of differential exposure to heat and differential effects of heat using a novel approach we will
develop in collaboration with the Research and Capacity Building Core. We will leverage expertise on health
disparities, biostatistics, urban planning, and policy translation at the Drexel Urban Health Collaborative (UHC)
and our partners in this project (UC Berkeley, INCAP, and University of São Paulo). We will accomplish the
following aims: 1) estimate intra-city heterogeneity in the temperature-mortality association; 2) investigate
associations of neighborhood social, built, and natural environment factors with differential heat impacts on
mortality; and 3) study the differential impact of heat on mortality by age, gender, race/ethnicity, and education.
We will contribute to the data infrastructure created by the Administrative Core, advance methods development
and training in partnership with the Research Capacity Building Core, and coordinate engagement of
policymakers with the Community Engagement Core. Specifically, we will develop dissemination and
engagement strategies using the results of our research projects that will influence policy in the cities of
interest but also inform future dissemination and engagement efforts. In addition, through this project we will
refine an approach to between- and within- city analysis from multiple countries, and conduct cross-country
multi-city comparative analyses that can be leveraged and expanded to multiple cities across Latin America
and the US in future work of the Drexel Climate Change and Urban Health Research Center.